Real-World Molecularly Targeted Treatment Registry (MaTTeR): a Pilot Study to Enrich CCDI Data Utilizing Directed Electronic Medical Record (EMR) Extraction

Project Summary Abstract
Integration of genomic profiling into the care of pediatric, adolescent and young adult (AYA)
patients with cancer has resulted in the identification of potentially targetable alterations and the
use of molecularly targeted therapies (MTT). Pediatric and AYA cancer patients are increasingly
treated with MTT outside of clinical trials. Systematic data collection and publication of MTT use
outside of clinical trials are lacking such that these real-world experiences are not optimally
contributing to the current understanding of MTT use in pediatric and AYA cancers. This project
will utilize genomic data previously contributed to the Children’s Cancer Data Initiative (CCDI)
as well as additional Dana-Farber Cancer Institute (DFCI) institutional cohorts to identify
patients with targetable genomic alterations. We will then identify patients who received targeted
therapies off of a clinical trial and extract key treatment data, including drug information, dose,
dosing formulation, combination treatment, duration of treatment, best response, time to best
response, duration of response, dose modifications due to toxicity, toxicities, manner of
treatment access (off-label, single patient investigational new drug (IND) protocol). The
systematic clinical data collection of MTT use of the CCDI cohort of patients proposed in this
project will serve as the proof of concept of accessing and enriching CCDI data with highly
valuable data that is otherwise imprisoned within the electronic medical record. This project will
establish the feasibility of creating a scalable registry of real-world targeted therapy experience
that can be expanded to additional CCDI datasets and serve as an important future resource for
the pediatric and AYA cancer community.

Public health relevance
Project Narrative The incorporation of genomic profiling into the clinical care of pediatric and AYA cancer patients has resulted in identification of targetable alterations and use of molecularly targeted therapies (MTT). There is a critical need to collect and report the outcomes (efficacy, dosing and toxicity) of real-world use of MTT outside of clinical trials to inform the ongoing and future role of these drugs in pediatric and AYA patients with cancer. This project will utilize existing genomic data contributed to the CCDI, pilot targeted clinical data extraction from the Electronic Medical Record (EMR), and establish an expandable and accessible resource for MTT treatment data for the pediatric and AYA cancer community.